Mechanisms of Double Strand Break Repair in Fetal Male Germ Cells

PROJECT SUMMARY
Male germ cells (MGCs) are precursors to spermatogonial stem cells (SSCs), a stem cell population that both
self-renews and differentiates, supplying spermatozoa for the entirety of a male’s reproductive lifespan.
Therefore, any genomic perturbation in MGCs caused by inaccurate DNA damage repair can be heritable. Just
prior to birth, MGCs undergo a relatively long period of cellular quiescence (G0). This period is required for SSC
development and is developmentally conserved between mice and humans. During this G0 phase, MGCs
experience hyper-transcription and changes in epigenetic modifications, two cellular activities that directly cause
DNA damage in somatic cells. However, little is known about the DNA damage that accumulates in MGCs during
this G0 arrest or how it is repaired to maintain fidelity of the germline genome. The most potent form of DNA
damage is double strand breaks (DSBs). DSBs are often repaired by one of two pathways, non-homologous end
joining (NHEJ) or homologous recombination (HR). NHEJ is an efficient, yet error-prone repair mechanism that
is used in the G0/G1 stages of the cell cycle. In contrast, HR, which requires a homologous template, is a more
complex, yet accurate repair mechanism that is used in S and G2 stages of the cell cycle. In G0 MGCs,
maintaining the integrity of the genome during DSB repair is of utmost importance. However, the mechanism in
which G0 MGCs repair DSBs is unknown. The overall objective of this K99/R00 proposal is to determine
how G0 MGCs respond to and molecularly repair DSBs and to elucidate the importance of G0 MGC DSB
repair in SSC development. The central hypothesis, which is based on preliminary data, is that G0 MGCs
employ a modified-HR mechanism that incorporates NHEJ proteins, using the homologous chromosome as a
template to repair DSBs and ensuring SSC development. In Aim 1 (K99 phase), single cell transcriptomics,
immunofluorescence, and genetic models will be used to define the pathway that MGCs employ to repair DSBs.
In Aim 2 (K99/R00 phase), a novel, in vivo CRISPR-Cas9 based assay will be generated and used to elucidate
the molecular mechanism of DSB repair. In Aim 3 (R00 phase), genetic models, single cell transcriptomics, and
single cell genomics will determine the implications of DSB repair defects in G0 MGCs on SSC development.
Data and skills obtained from the K99 portion of this proposal will provide the basis for a strong and innovative
independent research program, which will be expanded upon using data obtained from the R00 phase.
Completion of these Aims will require training in complex bioinformatic analyses and mouse genetics, and the
enclosed development plan describes a two-year blueprint designed to strengthen these skills. The research
and development plans will be implemented at Duke University in the laboratory of Dr. Blanche Capel. Overall,
the enclosed K99/R00 proposal can successfully transition a mentored scientist into a creative and skilled
independent researcher and significantly advance knowledge for the improvement of reproductive health.

Public health relevance
PROJECT NARRATIVE Male reproductive health is dependent upon the genomic fidelity of male germ cells (MGCs), the fetal precursor of spermatogonial stem cells (SSCs), and mechanisms ensuring fidelity in response to DNA damage in MGCs are largely unknown. The primary aim of this study is to elucidate how MGCs repair double-strand breaks (DSBs), the most dangerous form of DNA damage. Results obtained from this study can provide insight into how the male germline maintains genomic integrity between generations and across species, contributing to reproductive health.